Leveraging the chemo-physical interaction of halorespiring bacteria with solid surfaces to enhance halogenated organic compounds bioremediation

PROJECT SUMMARY
There is a lack of fundamental understanding on how microbial breakdown of chlorinated
organic compounds is influenced by the presence of sorptive surfaces. Several laboratory and
field studies have demonstrated a synergy between sorptive materials and microorganisms
leading to the development of material aided delivery of bioamendments in both groundwater
and sediment applications. However, a mechanistic understanding of the relationship between
sorptive surfaces and microbial dechlorination is lacking. To fill this critical knowledge gap, this
research team of chemical/environmental engineers and microbiologists will investigate the
fundamental mechanism of microbial dechlorination of chlorinated organics on sorptive surfaces
and develop quantitative models that allow optimization and engineering scaleup of enhanced
bioremediation aided by materials engineering. Improved understanding will allow better
prediction of the degradation of sorbed chemicals in the environment and enable optimization of
material science aided technologies for the delivery of biodegradation technologies.
The project will target chlorinated organics ranging from less hydrophobic compounds like
chloroethenes typically associated with groundwater and strongly hydrophobic compounds such
as PCBs typically associated with sediments. These pollutants will be investigated individually
as well as in mixtures that are commonly encountered at Superfund sites. A set of carbon-based
sorbent materials will be produced in the laboratory to provide a range of physical and chemical
properties. In addition to the lab synthesized materials, two most commonly used activated
carbons (bituminous coal based, and coconut shell based) and graphite will be tested in parallel
for comparison. Through systematic laboratory experiments, the physical and chemical
properties (such as specific surface area, pore size distribution, electron accepting capacity, and
carbon content) will be evaluated for influence on the sorption characteristics and synergy with
biodegradation of chloroethenes and PCBs. Final material selection will also be guided by
environmental sustainability considerations. Sorption and biokinetics data from the experimental
studies with optimized materials will be synthesized into advanced site models to predict
material behavior for field-scale remedial applications. Results from the modeling simulations
will allow for optimization of the engineering design for pilot and full-scale applications at
contaminated groundwater and sediment Superfund sites. This platform of combining tailored
materials with biodegradation will be adaptable for targeting other pollutant mixtures.

Public health relevance
PROJECT NARRATIVE This multidisciplinary research will explore the interaction between solid surfaces and microorganisms to improve quantitative understanding of microbial dechlorination kinetics. The new knowledge will be used in mathematical models to optimize bioamendment materials to enhance bioremediation. Collaboration with environmental consulting professionals will integrate the novel technology through advanced site models for evaluation of effectiveness at Superfund sites.